Hepatic Tissue Integrity and Clonal Fitness: Key Factors in Controlling β-Catenin Induced Oncogenesis

PROJECT SUMMARY
Given the importance of mutations in oncogenes and tumor suppressor genes, it has been widely assumed that
the mere accumulation of mutations is the primary process to explain cancer incidence. However, cancer is
predominantly a disease of aging, with its incidence remaining low until the fourth decade of life, undergoing
exponential growth thereafter. Furthermore, cells carrying well-characterized oncogenic mutations can be found
across normal human tissues, and can persist for decades without ever developing cancer. Our current
understanding of what factors govern this decades-long latency and eventual failure in aged tissues are
extremely limited. A compelling argument to describe this is tissue integrity in terms of its structure and function,
both of which decline with age, and could explain differential fitness for cells harboring oncogenic mutations. Our
ignorance of these tissue dynamic processes stems from our inability to perform in vivo analysis over such long-
time frames in relevant mouse models. We hypothesize that chronic liver disease (CLD) can be understood as
an accelerated aging of the liver that similarly alters the fitness landscape, promoting the selection of mutated
cells that progress towards hepatocellular carcinoma (HCC). We focused on CTNNB1 encoding for β-catenin,
as it is the most frequently mutated oncogene in human HCC, with ~30% of patients having alterations that
render β-catenin constitutively active. However, the precise mechanisms by which β-catenin mutations drive
HCC progression remain unknown. To address this knowledge gap, we have performed a long-term clonal
lineage tracing of hepatocytes bearing Ctnnb1 activating mutations in both the normal and in the chronically
injured liver. By coupling this tracing system with single cell RNAseq, we discovered that in the normal liver, β-
catenin mutated hepatocytes are incapable of undertaking a single cell division, but instead last for months in
the tissue through a long process of cellular attrition and elimination, which we hypothesize is primarily attributed
to ER stress and maladaptive UPR. Strikingly, in the context of CLD, we found that tissue injury unleashed the
potential of β-catenin mutated hepatocytes to clonally expand and drive the development of HCC tumors, solving
a longstanding conundrum in the field. Importantly, using the same lineage tracing system, we found that β-
catenin mutated hepatocytes in normal livers of aged mice can similarly undergo clonal expansion as observed
in CLD. In this proposal, we will investigate the specific molecular mechanisms that result in diminished cellular
fitness of β-catenin mutated hepatocytes in the normal liver and conversely, what mechanisms are behind the
increase in cellular fitness of β-catenin mutated hepatocytes during chronic liver damage. By focusing on these
mechanisms, we expect to lay the groundwork for exploiting the vulnerabilities of β-catenin mutated hepatocytes
found in the normal liver while blocking the strengths they acquire during CLD to tackle this devastating disease.

Public health relevance
PROJECT NARRATIVE We remain ignorant about the tissue dynamics that govern cancer development during aging or chronic tissue injury. One primary example is liver cancer, which is the third most lethal cancer worldwide and largely develops within a chronically diseased liver. By unraveling the mechanisms by which the most frequent oncogenic mutation in liver cancer interacts with the tissue microenvironment in both healthy and diseased livers, we can potentially unlock novel therapeutic interventions.